Defining the contributions of BRCA1, BRCA2, and RAD52 to genome stability

Project Summary
Our chromosomes are continually bombarded with a variety of insults, resulting in damage that must be
repaired. By necessity, cells have evolved mechanisms to detect and repair broken strands of DNA, thereby
preventing loss of important genetic information. Double-stranded DNA breaks (DSBs) are a type of
damage that can result in particularly disastrous outcomes. If not corrected, DSBs can lead to gross
chromosomal rearrangements, which are the hallmark of all forms of cancer. Indeed, defects in HR-related
proteins are associated with several severe genetic diseases. Patients with these diseases often exhibit a
strong predisposition for developing cancers due to a loss of genome integrity. Surprisingly, DNA
replication is the primary source of DSBs, and as a consequence rapidly growing cells are especially
dependent upon homologous DNA recombination for survival. This dependence upon homologous
recombination for the survival of rapidly growing cells highlights the potential for using recombination
inhibitors as highly selective anti-cancer therapies. To exploit the clinical potential of homologous
recombination inhibitors it will be essential that we more fully understand the molecular underpinnings of
the proteins that are involved in regulating and controlling recombination.
To help better understand the molecular basis of homologous DNA recombination we have developed
powerful new experimental platforms that allow us to directly visualize hundreds of individual DNA
molecules at the single molecule level. We are utilizing these unique research tools to probe the fundamental
basis for protein-nucleic acid interactions, with emphasis placed upon understanding reactions relevant to
human biology and disease. We have used these assays to study human RAD51, which binds to single-
stranded DNA forming a key recombination intermediate called the presynaptic complex. Here, we will
assess how complexes containing the tumor suppressor protein complexes BRCA1-BARD1, BRCA2-
DSS1, and PALB2 promote homologous recombination by regulating the activities of the RAD51
presynaptic complex. We will also examine how the protein RAD52, which newly recognized as an
important target for anti-cancer drugs, interacts with RAD51, BRCA1-BARD1, BRCA2-DSS1, and
PALB2. We will also study the protein RADX, which is emerging as a key player in genome integrity which
functions to downregulate RAD51 activity. We will accomplish these goals by directly visualizing these
processes in real-time using optical microscopy. These studies offer the potential for significant new
insights into how BRCA1-BARD1, BRCA2-DSS1, PALB2 and RAD52 regulate homologous
recombination and support human genome integrity.

Public health relevance
Project Narrative Homologous recombination is a DNA repair pathway, which plays crucial roles in genetic disorders, cancer and aging. Several tumor suppressor proteins are now known to participate in homologous recombination, and defects in these proteins are broadly associated with human cancers. Included among these are BRCA1 and BRCA2, which are key proteins involved in the early stages of homologous recombination, and are frequently mutated in hereditary breast and ovarian cancers. To help extend our understanding of how BRCA1 and BRCA2 participate in homologous recombination we have developed a powerful new experimental platform based on state-of-the-art optical microscopy that enables us to directly observe the proteins that participate in homologous recombination in real time. These powerful new research tools allow us to address questions in cancer research that cannot be tackled with more traditional experimental approaches.